A Comprehensive Self-Management Intervention for individuals with Inflammatory Bowel Disease

PROJECT SUMMARY/ABSTRACT
Individuals with inflammatory bowel disease (IBD) experience a high burden of symptoms including abdominal
pain, bloating, fatigue, sleep disturbances, anxiety, and depression. Yet, few self-management interventions
exist to reduce symptoms in this population. This proposed study will adapt an existing Comprehensive Self-
Management Intervention (CSM) with demonstrated efficacy in an irritable bowel syndrome population into a
population of individuals with IBD (CSM-IBD). The long-term training goal of this project is to assist Dr. Kamp in
becoming an independent investigator with a program of research focused on improving self- and symptom-
management among individuals with IBD. As such, Dr. Kamp has training competencies to increase knowledge
and skills in advanced training in conducting randomized controlled trials, longitudinal data management,
processing and analysis of microbiome data and leading interdisciplinary teams. The Specific Aims are to: 1)
determine the feasibility and acceptability of study procedures (recruitment, randomization, data and sample
collection) and the CSM-IBD; 2) compare the CSM-IBD intervention to usual care on changes from baseline to
3 months post-intervention in quality of life and daily symptoms (fatigue, sleep disturbance, psychological
distress, and GI symptoms); and 3) explore the association of symptoms with socioecological factors (age, sex,
race/ethnicity, diet), clinical phenotype (medications, disease distribution), and biological signatures
(microbiome, calprotectin) with symptoms at baseline and response to intervention (immediately post-
intervention). The expected outcome will be preliminary feasibility data to inform a future R01 study which will
examine the efficacy of the CSM-IBD. To accomplish the research aims and training goals, an interdisciplinary
mentorship team has been assembled with expertise in symptom science, IBD, psychology, interdisciplinary
research, RCTs, gut microbiome, statistics, and data management. The team, along with the vast array of
resources available at the University of Washington, are well-suited to transition Dr. Kamp into an independent
investigator. This research is significant because it will address an unmet need regarding self-management
among individuals with IBD and has the potential to not only significantly improve the quality of life but also
change the clinical management paradigm for individuals with IBD.

Public health relevance
Project Narrative Individuals with inflammatory bowel disease experience many symptoms which impact social and physical functioning as well as quality of life. Self-management interventions are needed to address the symptom burden experienced by individuals with inflammatory bowel disease. The proposed study has the potential to improve the self-management of this population.